Alzheimer's Disease (AD) and Vascular Brain Injury- related changes in longitudinal Magnetic Resonance Imaging associated with IntraindividualCognitive Variability in Aging American Indians

Project Summary/ Abstract
American Indians are at higher risk for Alzheimer’s disease and Alzheimer’s disease related dementia
(AD/ADRD) compared to the general population, yet dementia onset and frequency in this population are
understudied. American Indians have a disproportionate burden of diabetes and vascular brain injury along with
evidence of health disparities. Diabetes increases the risk of vascular disease, which accelerate Alzheimer’s
disease-related processes coexisting in mixed forms of dementia. Intraindividual cognitive variability (IICV), a
measure of variability in neuropsychological test performance within a person at a single timepoint, may be a
novel, low-cost, noninvasive biomarker of neurodegeneration and early dementia. We aim to characterize
associations between IICV, longitudinal changes in magnetic resonance imaging (MRI) measures related to
AD/ADRD, and diabetes among older American Indians. For this we will use data from the Strong Heart Study
(SHS) and Cerebrovascular Disease and its Consequences in American Indians (CDCAI) Study, calculating IICV
measures for memory, executive function and processing speed, and multidomain cognition for 403 American
Indians (age 70-95) who had diabetes assessments at three different timepoints over the course of ~27 years
(SHS Time 0, CDCAI time 1 and CDCAI time 2); neuropsychological and neuroimaging data at two time points,
with an interval of ~7 years (CDCAI time 1 and CDCAI time 2), and dementia adjudication at time 2. We will
accomplish this work through the following Specific Aims: (1) Examine (a) whether IICV at time 1 is associated
with neurodegenerative-related changes in MRI in critical brain regions (entorhinal, hippocampal, whole
brain atrophy), in American Indians, and (b) whether diabetes moderates this relationship. We expect (a)
that IICV will be positively associated with neurogenerative-related MRI changes, and (b) a stronger association
between IICV and MRI findings in those with diabetes at midlife (time 0) or later life (time 1 and 2); (2) Examine
(a) whether IICV at time 1 is associated with vascular brain injury in American Indians (WMH volume
progression), and (b) whether diabetes moderates this relationship. We expect (a) that IICV will be
positively associated with WMH progression, and (b) a stronger association between IICV and MRI findings in
those with diabetes; and (3) Examine whether (a) IICV at time 1 is associated with cognitive decline and
dementia adjudication at time 2, and (b) whether diabetes moderates these associations. We expect (a)
that increased IICV will be associated with an increased likelihood of cognitive decline, MCI, and dementia and
(b) a stronger association in those with diabetes. The validation of IICV as a marker of future AD/ADRD risk will
allow for earlier noninvasive identification and mitigation of risk in American Indians. Results from this study are
expected to advance the understanding of how IICV relates to neuropathology, dementia, and type 2 diabetes
among aging American Indians, and is expected to serve as preliminary data to optimize the design of a future
R01 dedicated to investigating the utility of IICV as early marker of AD in minority populations.

Public health relevance
Project narrative The proposed research is relevant to public health because it will determine if intraindividual cognitive variability can be used to identify early symptoms of neurodegeneration and vascular injury in American Indians, an underserved population with elevated risk of dementia due to high rates of cardiovascular disease, diabetes, and social vulnerability. The proposed work will identify less invasive ways to detect early signs of neurodegeneration, enabling earlier interventions to reduce the impact of dementia on individuals, their families, and their communities. The project is relevant to National Institute of Aging‘s mission because it will contribute new knowledge to differential diagnosis of symptomatic cognitive impairment and to develop biomarkers in asymptomatic individuals, expand and disseminate research on co-occurring conditions and dementia; and understand health differences and inequities associated with ethnic minority older adults.